DEVELOPMENT OF MYELO001 AS AN ORALLY APPLIED MEDICAL COUNTERMEASURE FOR THE TREATMENT OF HEMATOPOIETIC ACUTE RADIATION SYNDROME

The Contract was awarded to evaluate and develop a medical countermeasure for the treatment of Human Acute Radiation Syndrome (H-ARS) 24 hours post radiation.